Neural markers of late language emergence in preschool children born very and extremely preterm

ABSTRACT
Children born extremely preterm (EP; <27 weeks gestational age (GA)) and very preterm (VP; 28 – 32 weeks
GA)) are at high risk of having language-related deficits [1-5] compared to term-born control (TC) children.
Little is known regarding the neural mechanisms that contribute to the substantial variation in the rate of
language development in EP/VP children, with no explanation why some EP/VP preschoolers with delayed
language ‘catch up,’ while others receive a diagnosis of language disorder at school age. The PI’s team has
extensive experience obtaining brain function (magnetoencephalography (MEG)) and brain structure (magnetic
resonance imaging (MRI)) data in infants and young children, with studies from the PI and others showing that
variability in language development is due to between-subject variability in the maturation of neural-circuit
activity, such as variability across children in their ability to rapidly encode auditory information (i.e., measured
via the auditory M50 response latency [39]). Employing a longitudinal design and using multimodal
neuroimaging (MEG and MRI), this R01 will identify neural mechanisms contributing to the heterogeneity of
language trajectory in EP/VP children at 3, 4, and 5 years corrected age (CA), improving upon already
identified clinical and socio-demographic risk factors. This R01 leverages the PI’s current TALK supplement
study (3UG1HD068244-13S1), in which MEG, MRI, and language measures are obtained from EP (N = 60)
and TC (N = 60) children at age 3 years (Time 1). For this proposed R01, follow-up brain imaging and
language measures for these EP and TC children will be obtained at age 4 (Time 2) and 5 years (Time 3), and
a new cohort of VP children (N=60) will be recruited and assessed at all 3 time points (3, 4, 5 years corrected
age (CA)) to evaluate the specificity of findings across a broader spectrum of prematurity. Source localization is
used to examine neural-circuit activity associated with auditory encoding and with receptive and expressive
language processes in brain space. Study aims examine group differences in these auditory cortex and
language neural measures as well as determine the degree to which the neural measures (single-time-point
and rate-of-change) improve prediction of language trajectory and language outcome at 5 years CA, above
and beyond clinical/socio-demographic risk factors. The proposed R01 has high impact and captures the
maturation of language associated neural activity (local and network activity) that is associated with language
ability (current and future). It is anticipated that the elucidation of neural risk factors will provide increased
specificity with respect to the nature of variable language outcome in preterm preschoolers. Study findings will
advance our mechanistic understanding of neural circuit contributing to language delay and late talking in
preterm young children, the R01 study goals in line with the TALK Initiative goal “to create longitudinal datasets
and identify optimal measures for differentiating developmental trajectories in late talking children across time.”

Public health relevance
PROJECT NARRATIVE The proposed R01 employs a longitudinal design and multimodal neuroimaging to identify neural mechanisms contributing to the heterogeneity in language outcome in extremely preterm (EP), very preterm (VP), and term- born control (TC) preschool children at 3, 4, and 5 years old. Brain function (magnetoencephalography), brain structure (magnetic resonance imaging), and language and cognitive measures will be obtained at each time point to determine the degree to which neural measures improve prediction of language outcome, above and beyond clinical/socio-demographic risk factors. Study findings are expected to advance our mechanistic understanding of the development of typical and atypical language, and to identify neural processes (single time point and rate-of-change) associated with language delay and disorder in preterm young children.